Chemical Biology of the Visual Pigments

ABSTRACT: Visual pigments initiate the human visual experience, making them of great physiological interest,
and also are affected in retinal diseases. Accordingly, numerous research efforts have been devoted to
characterizing their structure-function relationships. Despite these efforts, critical gaps remain in our
understanding of visual pigment photochemistry and signaling properties. Knowledge of this fundamental visual
physiology is necessary to make accelerated progress in developing treatments for associated retinopathies. At
the heart of all visual pigments is a retinaldehyde chromophore that undergoes a cis-trans isomerization upon
absorption of a photon of a suitable wavelength. This complex reaction, which proceeds through several
photointermediates, triggers the conformational changes necessary for the propagation of a light stimulus into a
biochemical response. This photoactivation process ends with the hydrolysis and release of retinaldehyde, which
is required for renewal of the receptor light-sensitive state and hence continuous visual function. Fundamental
questions remain regarding receptor structure, mechanisms and modulators of hydrolysis of the retinaldehyde
Schiff base, and the modes of interaction of small molecule therapeutic candidates.
Here, we will pursue four specific aims that employ newly developed tools and approaches that we believe will
overcome previously insurmountable experimental challenges. 1) Elucidate structures of rhodopsin
photointermediates stabilized by nanobodies. Using a novel series of camelid antibodies that arrest the
rhodopsin photocycle, we will perform a detailed structure-function characterization of metarhodopsin
intermediates. 2) Define the kinetics of hydrolysis of the retinaldehyde chromophores of rhodopsin and cone
opsin pigments in native membranes. We have developed a novel mass spectrometry-based method that can,
for the first time, directly detect the retinal conjugation state of visual pigments in native membranes; we will
use this method to determine key rate constants necessary to model the interplay between visual pigment
bleaching cycles and the regenerative visual cycles. 3) Assess the influence of cytosolic effectors and visual
cycle components on the rate of hydrolysis of rhodopsin chromophore in knockout mouse models. Using the
methods described in Aim 2, we will characterize the rate of Schiff base hydrolysis in Arr1-/-, Grk1-/-, Abca4-/-,
and Rdh8-/- mice, providing new insights into how light and dark adaptation are modulated by
phototransduction and visual cycle proteins. 4) Characterize the molecular architecture of rhodopsin
complexes with lipids and small molecules using native mass spectrometry. Using the native MS technique, we
will quantify phospholipids that associate with rhodopsin in its various activation states. We will also validate
the pharmacodynamics and pharmacokinetics of small molecule therapeutic candidates in vivo. We believe the
information gleaned from these studies will enhance our understanding of retinal diseases at the molecular
level and enable the development of novel strategies for their treatment.

Public health relevance
NARRATIVE: Vertebrate vision starts with a photochemical isomerization reaction involving proteins known as visual pigments that contain retinaldehyde as their chromophore. Despite the fundamental nature of the process and its relevance to human physiology and disease, many of its properties remain poorly understood. Here, we employ a host of new approaches enabled by the development of novel experimental tools to address critical questions pertaining to the functioning of the visual pigments as well as their abnormalities in retinopathies.